MARC at University of Maryland, College Park

The MARC at Maryland is a three-year bioengineering undergraduate research training program that will break
down research barriers for students traditionally underrepresented in STEM by exposing them to research
opportunities and their benefits, facilitating positive interactions with research faculty, and enhancing financial
literacy. The number of underrepresented graduate trainees in biomedical sciences, particularly bioengineering,
still fall well below what would be representative of the current US population. The three key objectives of this
MARC program are to 1) increase the number of students from groups underrepresented in STEM that pursue
biomedical, research-focused higher degree programs (Ph.D. or M.D./Ph.D.), 2) support trainees in overcoming
barriers to entering research and preparing them for research careers, and 3) develop faculty mentors who will
enhance research pool diversity throughout their careers by training them in best practices in mentoring diverse
researchers. Our MARC program seeks to complete these objectives by integrating research training, mentor
training, peer mentoring, and financial literacy all while building a community for trainees that will provide them
with support in their biomedical research careers. MARC trainees will rotate through two mentor labs during their
first semester in the program and will be matched to work in mentor labs for the remaining 5 semesters until
graduation. MARC faculty and graduate mentors working with MARC trainees will be fully trained through the
“Entering Mentoring” and “Culturally Aware Mentoring” programs developed through rigorous peer-reviewed
methods by the Center for the Improvement of Mentored Experiences in Research (CIMER), to ensure an
inclusive environment. Our program also includes a one-credit course that integrates best practices in active-
learning-based teaching and will feature a “flipped” style of research training consisting of a comprehensive set
of research training workshops/lectures followed by in-class activities on classic topics including research training
(e.g. rigor, making figures, scientific communication) and career development (e.g. guidance on
fellowship/internship/graduate school applications). In addition, we aim to build a community for students through
semi-formalized peer mentoring, weekly activities such as Lunch and Learn and study halls, and annual program
retreats. Uniquely, we have partnered with Moore Wealth to integrate a 5-pillar financial literacy program into our
1-credit class. This is particularly important, as Black or African American students graduate college with on
average $4000 more debt than white students and underrepresented students often face additional financial
pressures. Moore Wealth’s financial literacy program is developed by and for students of color and includes
topics such as credits and loans, investing, and navigating career transitions from the financial perspective.
Altogether, we propose a comprehensive program that provides support to trainees from underrepresented
groups in research training and beyond with the main aim to increase representation in bioengineering at the
graduate level.

Public health relevance
Project Narrative We propose a three-year bioengineering undergraduate research training program that will expose a diverse population of students from underrepresented backgrounds to existing research opportunities, facilitate multiple positive interactions with participating faculty, as well as build the trainee’s cultural capital and sense of community through our six-semester one-credit required course and three-year research experience in the laboratories of our faculty mentors. Our goal is to use evidence-based best practices to prepare our trainees for a career in biomedical research.